The Epitranscriptome as a Novel Mechanism of Arsenic-Induced Diabetes.

Project Summary
The primary goal of this research project is to investigate extracellular vesicle-derived microRNAs (EV-
miRNAs) as a potential mechanistic biomarker of arsenic (As)-associated type 2 diabetes mellitus (T2DM), and
its related conditions, in American Indians (AIs). The proposed research is a supplement to an ongoing R01
that is investigating the epitranscriptomic RNA modification N6-methyladenosine as a mechanism of As-
induced T2DM from AIs participating in the same cohort. The candidate for the diversity supplement is a
second year postdoctoral researcher in the Department of Environmental Health Sciences at Columbia
University in the Laboratory of Precision Environmental Health. The candidate is of Native Hawaiian descent,
and is to our knowledge, the only Native Hawaiian at the postdoctoral level at Columbia University. Throughout
the proposed research and career development training, he will have a strong mentorship team composed of
co-mentors Dr. Navas-Acien, PI of the parent R01, and Dr. Baccarelli, co-PI of the parent R01, with additional
support from a junior faculty member leading the research team of the parent R01, Dr. Kupsco. The candidate
is responsible for the completion of the proposed aims of the research project, including 1) characterizing
circulating EV-miRNAs that are associated with As exposure and As metabolism using next-generation RNA
sequencing targeted to small RNAs in AIs enrolled in the Strong Heart Study (SHS); 2) identify EV-miRNAs
that associate with T2DM risk, including insulin resistance, hyperglycemia, and metabolic syndrome, as well as
incident/prevalent T2DM; 3) investigate whether EV-miRNAs mediate the relationship between As and As
metabolism, and T2DM-related outcomes; and 4) identify biological pathways linking EV-miRNA signatures of
As-associated T2DM with changes in epitranscriptomic signatures. Throughout the proposed research, the
candidate will have a structured training plan that will facilitate the acquisition of skillsets necessary for his
short-term goal of acquiring a K99/R00 career transition award and his long-term career goal as an
independent academic researcher, this experience and training include, 1) advanced computational
approaches for population-based research, high-dimensional data, and molecular epidemiology; 2) community-
based and Indigenous health research approaches for cardiometabolic diseases; 3) grant writing for federal
funding; 4) authoring and communicating Indigenous Health Research; and 5) navigating a career in academic
research. To facilitate these training goals, the candidate will be involved in several formal training
opportunities offered through Columbia University, he will garner experience through involvement on the parent
R01, and he will meet weekly with members of his mentorship team.

Public health relevance
Narrative The proposed research for this diversity supplement will examine extracellular vesicle-derived microRNAs as a potential mechanism of arsenic-associated type 2 diabetes mellitus from American Indians enrolled in the Strong Heart Study. The candidate for this diversity supplement is a postdoctoral fellow in the Department of Environmental Health Sciences at Columbia University, where his research focuses on identifying potential epigenetic mechanisms at the interface between environmental factors and health. Through this diversity supplement, the candidate will gain fundamental skills and experiences necessary for his career goal as an independent academic researcher and leader in epigenetic epidemiology and Indigenous Health Sciences.